Human stem and progenitor-based models of lung adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Non-small cell lung cancer (NSCLC) is one of the leading causes of cancer-related mortality worldwide. Lung
adenocarcinoma (LUAD) is the most common subtype of NSCLC. Genetically engineered mouse models
(GEMMs) in which expression of mutant oncogenes and/or deletion of tumor suppressors leads to the formation
of autochthonous tumors are the most commonly used models in lung adenocarcinoma research. Although the
lesions generated in these models histopathologically resemble human tumors, they differ in their molecular
characteristics. Unlike human tumors, murine ones lack high mutational burden. Our preliminary evidence
highlights that the anatomical region from which lung adenocarcinoma arises is significantly different in murine
and human lungs. Further, the epithelial stem and progenitor composition and their lineage trajectories are
distinct in mice and people. Notably, previous studies have shown that GEMMs are non-responsive to single ICI
therapies. All these reasons point towards the need to develop novel human-relevant lung adenocarcinoma
models. As an alternative model to GEMMs, patient-derived organoids (PDO) and patient-derived xenografts
(PDX) in mice have been proposed to evaluate tumors. Although well suited for personalized therapy, PDO and
PDX models are limited in availability, lose their original characteristics with passaging, and are not easily
controlled for the mutations and tumor stage being studied. These technical limitations have made it difficult to
dissect the mechanisms influencing human lung tumor cell plasticity. To overcome these limitations, we seek to
model tumors by genome editing primary human lung cells and culture them as tumor organoids or orthotopically
xenograft them into mice. In Aim 1, we seek to introduce oncogenic mutations into two primary human lung stem
and progenitor populations and generate organoid models. These models are amenable for high throughput drug
testing in the future. Further, in Aim 2, we will xenograft the mutated stem/progenitor populations into lungs of
immunodeficient mice to develop an in vivo model. We will perform histopathological analysis to compare the
resulting tumors to primary human lung adenocarcinoma. We will further perform single cell transcriptomics to
characterize the tumor cell states and dissect the role of cell of origin in determining histopathology of tumors
and tumor cell states. In brief, we seek to develop novel lung adenocarcinoma models that better capture the
initiation, progression and composition of primary human LUAD tumors, and characterize the cell of origin
dependent effects on the resulting tumors.

Public health relevance
PROJECT NARRATIVE Lung cancer is a devastating disease accounting for 1 out of 5 cancer related deaths. In this study, we aim to develop improved human-relevant models which will assist in testing novel therapies.